Vevo F2 Ultrasound Imaging System

Project Summary/Abstract
The Fujifilm VisualSonics Vevo F2 is the current, state-of-the-art preclinical ultra-high-low frequency imaging
system that combines a robust collection of features designed to improve and optimize image acquisition time,
accuracy, and resolution. This instrument will provide users at UT Southwestern with an in vivo cardiac
phenotyping platform capable of facilitating multiple cutting-edge, NIH-funded research objectives. With this
resource, users will be able to obtain accurate non-invasive measurements of the structure and function of the
heart and blood vessels in small animals. Additionally, users will be able to interrogate internal organs and
embryo morphology, as well as the perfusion of internal organs. The Vevo F2's advances in image clarity,
coupled with additional imaging modes, such as 4D imaging, and faster acquisition rates, will allow users to
decrease technical variation related to poor image quality. Additionally, this advanced system will greatly improve
throughput of data acquisition and reduce biases in scoring of cardiac function through use of artificial intelligence
and machine learning algorithms (anticipated for the future), thereby helping to standardize measurements.
Furthermore, advances in acquisition gating and image reconstruction permit the Vevo F2 to acquire 4D images,
providing outstanding temporal and spatial resolution of 3D renderings of internal structures such as the heart
and major blood vessels, permitting spatially unbiased assessment of these structures. In summary, the Vevo
F2 represents an exciting and necessary advance in the in vivo imaging capabilities at UT Southwestern, and it
has the potential to enhance and accelerate significantly our NIH-funded cardiovascular disease research goals.

Public health relevance
Project Narrative: Heart disease is unsurpassed as the greatest non-infectious health hazard ever to confront the human race. It is estimated that 5 million Americans have heart failure (HF), a syndrome with 5-year mortality of ≈50%. Indeed, HF has remained the leading cause of death in industrialized nations for some years. Accordingly, HF, the end- result of pathological cardiac remodeling, is responsible for a huge societal burden of morbidity, mortality, and cost. State-of-the-art preclinical ultrasound imaging with an instrument such as the VisualSonics Vevo F2 is pivotal to efforts to elucidate causes and potential therapies targeting this major health issue.